Dynamic Modeling of Dicer Function

Project Summary
It has been well established that small non-coding RNAs, such as microRNA (miRNA) and small interfering RNA
(siRNA), act as potent regulators in numerous biological processes. MiRNA, for instance, modulate gene
expression by targeting mRNA based on sequence complementary via the RNA Induced Silencing Complex
(RISC). This allows miRNA to regulate key cellular events including cell differentiation, proliferation, and
apoptosis. Consequently, when expression levels of miRNAs are dysregulated or alterations to the miRNA
sequence occur, individuals can become more susceptible to the development of a variety of disease types, such
as cancer, immune-related and neurodegenerative diseases. In response, researchers have been using a
combination of techniques to identify the mechanism(s) behind points of dysregulation to guide future RNA-
targeted therapeutics. Towards this goal, extensive studies have been carried out to identify and characterize
the proteins involved in the miRNA biogenesis pathway, which include the endoribonuclease III protein Dicer.
Dicer performs the final cleavage reaction to remove the hairpin loop region of precursor miRNA (pre-miRNA) to
produce mature miRNA strands. While in humans, Dicer’s role is centralized around miRNA maturation and
regulation, exploration into Dicer proteins from other species has revealed a highly dynamic and multifunctional
activity, which includes the cleavage of siRNAs, a key component in antiviral defense. Differences in substrate
specify are seemingly dependent on the ATP hydrolysis activity of Dicer’s N-terminal helicase domain. To further
investigate this functionality and determine its connection to substrate specificity, structural and biochemical
studies have been implemented to uncover the mechanisms behind ATP-independent vs ATP-dependent
helicase activity. However, these approaches have been unable to capture the conformational heterogeneity
associated with this functionality. Therefore, this proposal puts forth a new approach that combines results from
a series of molecular dynamics simulations used to investigate Dicer’s flexibility (Aim 1) with published
experimental observations from biochemical, kinetic, and structural studies to create data-informed predictive
simulations (Aim 2). These predictive simulations will be used to investigate the central hypothesis of this
proposal which is that the overall flexibility of Dicer’s helicase domain is dependent on whether it can hydrolyze
ATP, and that in the absence of this activity, the helicase domain is unable to maintain one stable structure and
samples a variety of conformational states. Overall, with the extensive resources offered by the University of
Utah and expert guidance provided to me by my mentors, I am confident that this proposal will not only generate
the first comprehensive integrative dynamic model of Dicer function, but also introduce a novel workflow to
explore hypotheses and predict related functional outcomes of other disease-associated RNA interactions.

Public health relevance
Project Narrative The RNase III enzyme Dicer is a highly dynamic and multifunctional protein that plays an important role in the maturation and regulation of small non-coding RNAs. Unfortunately, current approaches to study the conformational changes and molecular interactions associated with Dicer function have been unable to answer key questions regarding Dicer’s mechanism(s) of action related to substrate specificity and helicase activity. In response, this project will focus on developing a new approach that involves the use of data-informed predictive simulations, which combine physics-based and knowledge-based simulations with 3D animation software, to build integrative dynamic models of Dicer function with the goal of answering these mechanistic questions.